HIV VACCINE PRODUCTION

The objective of this contract is to produce, scale-up, characterize and formulate reagent grade (GLP) and /or clinical grade (cGMP) HIV-1recombinant whole-killed vaccine products for animal and/or human trials. For clinical grade materials the manufacturer must perform all required vaccine lot characterization tests. The contractor must also work together with other contractors performing safety and immunogenicity testing of the vaccine product or producing FDA-required documentation in support of an IND.